Administrative Core

PROJECT SUMMARY
The overall goal of the Administrative Core of the Digestive Health Center (DHC) is to develop and
implement an administrative structure that integrates key functions of the Center. The Core Aims are 1) to
implement an administrative structure that integrates key functions of the Center, 2) to develop a succession
plan that ensures the pursuit of excellence and long-term viability of the DHC, 3) to foster Center membership
by innovative investigators committed to studies of digestive diseases, and 4) to increase visibility and expand
digestive disease research. The Center management, day-to-day operation, and general oversight will be the
responsibility of the Leadership Committee, which consists of the Center Director, three Associate Directors,
and a Center Manager. The leaders have independent research programs and bring complementary skills to
the Committee. Each Associate Director is responsible for either the Enrichment Series, Clinical Component,
or Pilot and Feasibility Program. They meet weekly to review the operation of the Center. Six to 8 times a year,
members of the Leadership Committee meet as an Executive Committee, which also includes the Directors
of the Biomedical Cores and two DHC investigators representing the membership at large. The function of the
Executive Committee is to assist the leadership in reviewing Core utilization, provide support with scientific and
overall directions of the DHC, and help with conflicts arising from membership applications. Once a year, or
more often, the Executive Committee meets with the Internal Advisory Board to review strategic needs of the
Center and maintain institutional support to foster digestive disease research. This operational structure has
promoted collaborations among our Research Base of 68 investigators, who have published 630 articles in the
past 4 years and attracted ~$36.5 million in direct funds for digestive disease research. The Enrichment
Program fosters additional scientific development and a successful Pilot and Feasibility (P/F) Program
supports the career development of junior investigators. Overseeing the strategic operation of the DHC is an
External Advisory Board (EAB) comprised of four extramural scientific leaders. The EAB evaluates ongoing
research and programmatic directions of the Center, reviews, identifies, and recommends support for the most
meritorious P/F applications, and assesses the effectiveness of the Administrative and Biomedical Cores. The
EAB prepares and submits an annual report to the Chair of Pediatrics and Director Research of the
Research Foundation, who holds the primary reporting authority and oversight of the Center. The
Administrative Core structure and operation have been very effective over the past 14 years of the DHC
existence, have maintained the DHC as a real catalyst of scientific discoveries, have ensured the delivery of
state-of-the-art services that meet the needs of Center investigators, have implemented successful enrichment
and P/F programs, and have fostered an exceptional level of engagement and support from Cincinnati
Children’s Hospital Medical Center to be real catalysts of meaningful discoveries in digestive diseases.